EFFECTS OF ORAL CONTRACEPTIVES ON FREE FATTY ACID METABOLISM IN WOMEN

The purpose of this study is to determine whether oral contraceptive medications affect the release of fatty acids from fat tissues in normal weight, adult women.